Generation of a new model for Usher syndrome.

Summary
Mutations in USH2A (usherin) are common causes of autosomal recessive blinding diseases in
non-syndromic retinitis pigmentosa as well as syndromic Usher syndrome type II that manifests
congenital hearing loss as well. There is no effective therapy for these diseases. How usherin
contributes to photoreceptor health is poorly understood. An usherin-deficient animal model that
exhibits severe retinal degeneration as in human patients is essential for understanding the
pathological mechanisms and for development of effective therapies to preserve or restore vision.
This project is aimed at generating an usherin-deficient model that recapitulates the phenotypes found
in human patients.

Public health relevance
Project Narrative This research is relevant to public health because Usher syndrome type II are genetic diseases that causes blindness through degeneration of the retina. The goals are to generate appropriate models for testing experimental therapeutics for retinal degeneration.